Advanced Prediction of Emerging Respiratory Decline with the Linshom Continuous Predictive Respiratory Sensor (CPRS)

This SBIR research will demonstrate a superior method of respiratory monitoring that will be
first to enable continuous predictive respiratory monitoring (CPRM) at the patient bedside and in
the future at the pa*ent’s home. This research (phase 1 and 2) and innovative product research
& development (phase 2) will enable commercialization of the Linshom CPRM that will move
the entire field of respiratory monitoring from responsive (too late) to predictive, where patient
respiratory decline is identified when health care providers can take action and pre-empt patient
decline (i.e. rapid response activations, codes, ICU transfers). This will reduce morbidity,
mortality and healthcare expense. The engineering research (phase 2) will re-design and
miniaturize the sensor technology allowing these developments to be embedded in multiple
additional, smaller form factors (i.e. nasal cannula, home use) to reach more patients in need of
continuous, predictive respiratory monitoring.

Public health relevance
LINSHOM MEDICAL, INC.: has exclusive access to the facilities and resources of Artep Inc. Artep has over 35 years’ experience developing embedded controllers and data acquisition and instrumentation systems. Our engineers have all of the tools necessary to design, develop and test electronics and software real time embedded systems. Those tools include electronic CAD, software IDE, Compilers, Linkers, downloaders, emulators for embedded development, laptop development systems, LabView based Bench Checkout Equipment, power supplies, oscilloscopes, electronic benches for prototype builds, cable fabrication, electronic test equipment and SOLIDWORKS for mechanical design. The tools and equipment also exist for testing and verifying the Linshom respiratory monitor verses calibrated ventilators, Capnographs, and ventilator calibrating equipment (PFC-3000 Flow Analyzer). Over the years the Artep team of scientists and engineers provided an array of products and services to NASA, the Naval Research Laboratory, the U.S. Air Force, Lawrence Livermore National Laboratory, Sandia and public universities around the country and abroad. Instruments designed by Artep have flown successfully on more than 15 launch vehicles and have been fielded in many laboratory experiments. Artep, Incorporated, has produced space flight instruments for satellites, space shuttles, sounding rockets and research laboratories for over 35 years. Artep specializes in supporting scientific projects ranging from small experiment groups to large-scale research institutions and the military. Artep will design, fabricate, test, and integrate our custom hardware. Artep provides complete support in all key project areas, including Software Design, Electrical Engineering Mechanical Engineering Materials Selection, Optical Design. Linshom/Artep has over 35 years’ experience developing embedded controllers and data acquisition and instrumentation systems. Our engineers have all the tools necessary to design, develop and test electronics and software real time embedded systems. Those tools include electronic CAD, software IDE, Compilers, Linkers, downloaders, emulators for embedded development, laptop development systems, LabView based Bench Checkout Equipment, power supplies, oscilloscopes, electronic benches for prototype builds, cable fabrication, electronic test equipment and SOLIDWORKS for mechanical design. The tools and equipment also exist for testing and verifying the Linshom respiratory monitor verses calibrated ventilators, Capnographs, and ventilator calibrating equipment (PFC-3000 Flow Analyzer). Over 3 decades, the Artep team of scientists and engineers provided an array of products and services to NASA, the Naval Research Laboratory, the U.S. Air Force, Lawrence Livermore National Laboratory, Sandia and public universities around the country and abroad. Instruments designed by Artep have flown successfully on more than 15 launch vehicles and have been fielded in many laboratory experiments. Artep, Incorporated, has produced space flight instruments for satellites, space shuttles, sounding rockets and research laboratories for over 35 years. Artep specializes in supporting scientific projects ranging from small experiment groups to large-scale research institutions and the military. Artep along with our industry partners can design, fabricate, test, and integrate our custom hardware. Inhouse Software CAPABILITIES – Real-Time Operating Systems (RTOS) – Custom instrument Control – Data Acquisition systems – End to End Testing and Verification – Custom GUIís – C, C++, Labview, Assembly Artep facilities include: - office space - Dedicated area for Software development - Electronic Design Tools and CAD - Printed Circuit Board (PCB) Design Tools and CAD - Flex PCB design tools and CAD - testing and integration lab